Role of Data Streams In Informing Infection Dynamics in Africa- INFORM Africa

Title:
An Exploratory Research to Quantify SARS-CoV-2 Related Health Effects
under Extreme Climate Events
Abstract:
This novel Pillar-1 “Health Effects Research” will evaluate the role that
climate-change and its resulting extreme weather events have on SARS-
CoV-2 related health outcomes. There is an urgent and ongoing need of
such evaluation to understand the complex and compound effects in
preparation for the new SARS-CoV-2 waves and future pandemic. We
propose to develop geospatial models to identify how COVID-19
transmissions risks, cases, and deaths are directly related to climate events
and therefore quantify the spatial heterogeneity. This research will also
explore the use of mobile phone location data sources to identify behavioral
and economic changes. Novel human mobility, density, and accessibility
indicators will be developed and statistically tested to measure movements,
gathering behavior, evacuation, and access of food, healthcare, etc. Such
human behavior and changes will again be integrated into a geospatial
model to estimate the indirect effects of climate change on health. The
impact of climate events may have direct health consequences, but also
feedback effects from the induced human gathering and reduced
accessibility to food, healthcare and other essential businesses. The
proposed study will innovatively quantify such effects of the public health
crisis. The highly data rich and disaggregate research approach would also
enable the quantification of health effects, social and health disparities
faced by vulnerable and underserved populations.

Public health relevance
PROJECT NARRATIVE: This novel Pillar-1 “Health Effects Research” investigates the influence of climate change and extreme weather events on SARS-CoV-2 related health outcomes. The study has the spatial and temporal focus on extreme weather events in Nigeria and South Africa, explicitly quantifying the direct health impacts from climate change on the weather-impacted areas, indirect impacts caused by induced human behavior changes and on different population groups, and the spillover influences on connected neighboring regions. The proposed study innovatively applies techniques from statistics, data sciences, computer science, and public health to deliver actionable results as well as data and new measurements to understand the health effects of extreme climate events on SARS-CoV-2 outcomes. BACKGROUND AND RATIONALE Background The proposal team works together under the “Role of Data Streams in Informing Infection Dynamics in Africa (INFORM Africa)” Research Hub, aiming to effectively use big data to address pressing public health needs of SARS-CoV-2 and HIV epidemics with the overall goal of developing population-scale data streams as a cornerstone of future pandemic preparedness. Under INFORM Africa, the team has developed a customized survey to measure the adoption of SARS-CoV-2 public health measures in Nigeria and South Africa and will begin data collection soon. In the meantime, nationally available datasets are being pulled and integrated to estimate social vulnerability index. Statistical models are being built to quantify disease- transmission risk and its relationship with socioeconomic, demographic, and climate-related factors. The team has also examined the effect of movement-based restrictions on mobility, comparing pre- and post-pandemic patterns in cell phone mobility data and connecting specific patterns with SARS-CoV-2 risk. Cloud-based data science and machine learning algorithms have been developed and tested to process, recognize, and model human activities and health- related measurements using tens of millions of samples in the two countries (Figure 1 visualizes a snapshot of human activities in the first week of August, 2020 in Nigeria). Figure 1. Density Plot of One Week of Human Activities in Nigeria (Data Coverage: August 1-7, 2020) Leveraging these accumulated and most relevant modeling and big-data expertise and experiences, the team proposes to conduct a “Health Effects Research” (Pillar 1) studying how climate change and the resulting extreme weather events affected SARS-CoV-2 health outcomes. The study area will focus on Nigeria and South Africa, two countries that frequently underwent weather disasters. Nigeria has two precipitation regimes: low rainfall in the north leading to high likelihood of aridity; much greater precipitation and chance of large-scale flooding in the south (e.g., Akande, et al., 2017). Flooding risks have increased two to three times in South Africa. These climate-change extreme events would exacerbate SARS-CoV-2 health outcomes both directly and indirectly. The effects can often be unequal, as climate change interacts with existing social and economic inequalities. In the proposed study, the team will quantify SARS-CoV-2 transmissions risks and health outcomes under extreme weather conditions using geospatial data intelligence, novel measurements of human mobility and density, and accessibility via emerging data-driven approaches. Impact and Innovation: This proposal is significant because the impact of climate change on SARS-CoV-2 health effect is under-researched, under-funded, and not well understood, and yet relevant not only for localities influenced by the extreme weather events but for regional health and economic policies. It is innovative because it applies techniques from statistics, data sciences, computer science, and public health to deliver actionable results as well as data and new measurements, such as data-driven human mobility metrics (e.g., shelter-in-place behavior, evacuation and gathering behavior, access to food/healthcare under extreme weather). The new measurements, data, as well as modeling methodology and findings, will be shared publicly to enable further scientific research.